Training Grant in Academic Gastroenterology

This renewal T32 application seeks to extend funding to a thriving research training program in the NIDDK
mission areas of adult and pediatric gastroenterology and Hepatology at the Stanford University. The main
goal of the Training Program in Gastroenterology is to recruit the most talented young physician-scientists in
basic, translational, clinical and population-based research and train them to be future leaders in academic
gastroenterology. The Training Program has a well-functioning governing structure consisting of a highly
motivated Program Director with a very strong track record of research training and NIH funding, and
Oversight, Selection, Mentorship and Evaluation Committees. Additional support is obtained from an
Administrative Subcommittee and an Internal and External Advisory Committees.
The Program includes faculty in the adult and pediatric GI Divisions and exceptional scientists at Stanford who
have strong track record of mentoring trainees in GI. The mentors cover a wide range of expertise providing a
comprehensive and interactive training including (1) basic biology of enteric and hepatic pathogens and the
development of novel therapeutic strategies; (2) host-microbiome interactions; (3) mucosal immunology; (4)
liver pathophysiology; (5) cancer genomics and biology; (6) bioengineering and medical device development;
(7) population science and epidemiology; and (8) health services and clinical outcomes research. For trainees
in the latter categories, Master’s degree program in epidemiology, health policy/services research or
biomedical informatics are offered and financially supported.
The Training Program is structured to optimize its operations in (1) selecting the best candidates, including
women and underrepresented minorities, (2) facilitating mentors to create the most productive research
training experience, (3) monitoring trainees’ progress and providing necessary support, and feedback, and (4)
critically evaluating the Program for continuous improvement.
The program is enriched by Stanford’s strong academic environment and commitment to train physician-
scientist leaders of the future. This is exemplified by resources ranging from infrastructure, personnel, and
financial support from the adult and pediatric GI Divisions to a diverse array of institutional programs promoting
research education. Thanks to these, our Program has excelled and majority of our graduates from the last
cycle are pursuing an investigative career, in academic institutions.
We propose to continue the strong tradition of physician-scientist training, adherence to all ACGME
recommended practices within fellowship training, and establish a more enhanced focus on diversity, inclusion
and wellness of our trainees and faculty, and seek to enhance it to best prepare our trainees for the future of
digestive medicine.

Public health relevance
The Training Grant in Academic Gastroenterology at Stanford University, in the past 46 years has supported research training to prepare the best-qualified physician-scientists for an investigative career in digestive diseases. Based on the strong track record, environment and pipeline of outstanding trainees, we are committed to provide the best training possible to prepare our fellows as future academic leaders in digestive medicine.